Building BRIDGEs: Coordinating Standards, Diversity, and Ethics to Advance Biomedical AI

OVERALL: ABSTRACT (PROJECT DESCRIPTION)
Bridge2AI is a signature NIH initiative. It recognizes the challenges and opportunities in the growth of data sci-
ence and data-driven methods for biomedical and behavioral research and healthcare delivery. We have reached
a key moment: with the exponential growth of our ability to collect and analyze data, we must consider how we
use this information to benefit everyone in an equitable way, providing a collective path forward. Data Generation
Projects (DGPs) within Bridge2AI will tackle “grand challenges”: questions that will shape future scientific dis-
covery and can ultimately impact the health and care of many. Marshalling these forces collectively requires
experience and insight to create a collaborative, interdisciplinary endeavor that brings together disparate stake-
holders to realize Bridge2AI’s mission: discovery, collaboration, and learning.
Building from our collective experience in successfully guiding large NIH initiatives and (inter)national scientific
consortia, our BRIDGE Coordination Center (CC) is designed to ensure a responsive set of Cores that will sup-
port and enable the DGPs in their grand challenges. Representing multiple institutions (UCLA, Penn State Uni-
versity, University of Florida, University of Michigan, University of Southern California, Oregon Health & Sciences
University, Sage Bionetworks, EMBL-EBI), we propose multiple interacting Cores. These Cores have interdisci-
plinary expertise across several key areas, including biomedical informatics/data science and AI (methods, ap-
plications, evaluation), as well as across different domains and data types. Our Cores (Ethics, Standards, Tool
Optimization, Skills & Workforce Development) are ready to interact to facilitate cross-cutting activities related to
ethics and trustworthy artificial intelligence (ETAI); FAIR principles (findable, accessible, interoperable, reusable)
across emergent datasets and domains; comparison and benchmarking of developed AI-ready datasets and
tools. Across our CC we will create a basis for diverse trainees to not only appreciate the implications of AI in
biomedical/behavioral research, but to meaningfully engage with them – embracing the heterogeneity of experi-
ences, backgrounds, and objectives to maximize the richness and strength this diversity brings in our actions.
We plan to work with a Teaming Core to enable activities that bring together disparate groups within Bridge2AI.
Our efforts are organized by a skilled Administrative Core who will provide oversight and cohesion to this en-
deavor, both across the Cores as well as with the DGPs and NIH. Our Cores are shaped to maximize the inte-
gration and sharing of ideas across the DGPs and Bridge2AI as a whole through dynamic, contemporary com-
munication methods; the refinement and dissemination of best practices between these groups and wider sci-
entific community through multiple venues; and the evaluation of the effectiveness of the methods and overall
Bridge2AI initiative. This CC will provide a unified framework for Bridge2AI to engage and education different
stakeholders, and together blaze a collective trail forward for biomedical and behavioral AI – for everyone.

Public health relevance
OVERALL: PROJECT NARRATIVE Artificial intelligence (AI) and its associated data-driven methods are rapidly changing how we analyze biomedi- cal and behavioral datasets – but they are not at all perfect. The Bridge2AI Initiative is a transformative oppor- tunity to discover how AI can better serve everyone, realizing its potential promise to improve health and healthcare for all. Our BRIDGE Coordination Center will provide a cohesive organization across the Cores tack- ling the emergent sociotechnical issues surrounding the use of AI, working closely with the Bridge2AI Data Gen- eration Projects to ensure a successful and productive outcome for this landmark NIH initiative.